PARTIAL SUPPORT OF THE FAST-TRACK CONSENSUS STUDY ON FOUNDATIONAL RESEARCH GAPS AND FUTURE DIRECTIONS FOR DIGITAL TWINS

PARTIAL SUPPORT OF THE FAST-TRACK CONSENSUS STUDY ON FOUNDATIONAL RESEARCH GAPS AND FUTURE DIRECTIONS FOR DIGITAL TWINS